Conference on Reproductive Psychophysiology

DESCRIPTION (revised by applicant): A four-day conference on reproductive psychophysiology is proposed to be held from July 12 - 15, 2003 at the Indiana Memorial Union Hotel & Conference Center, Indiana University, Bloomington. The main goal of the conference, the first ever to be organized on this topic, is to bring together researchers in to present up-to-date reviews of their research, to discuss commonalities and differences in conceptual and methodological approaches, and to suggest directions for future research. A secondary goal is to work towards a consensus in psychophysiological measurement and analysis procedures. This conference will address psychological, physiological and behavioral processes of critical importance to reproductive health and functioning, and will examine the interactions of these processes. The objective is to evaluate our understanding of relevant mechanisms and processes, to assess the extent to which this understanding allows us to predict and explain sexual problems, preferences, behavioral functioning, and to identify issues and topics important for future research. The conference will consist of two parts: a scientific meeting (July 13 - 15) and a pre-conference methodology workshop (July 12). The meeting will be restricted to invited participants. In addition to a panel of about 25 experts, we will invite approximately five graduate students to participate as speakers, as well as three undergraduate or graduate students who will be selected from a larger pool of applicants. All discussions will be recorded, transcribed and edited for publication, together with the presentation papers, as a monograph. In addition, selected members of the pre-conference workshop will work together to formulate and publish guidelines for psychophysiological measurement.